Dopaminergic Gut-Brain Signaling on Adolescent Reward Learning After Adversity: Toward New, Noninvasive Treatments for Depression and Anxiety

ABSTRACT
Approximately 2 in 10 American adolescents have experienced major depression in their lifespan, and 3 in 10
have experienced an anxiety disorder. Despite the clear

Public health relevance
PROJECT NARRATIVE The high prevalence of anxiety and depression in adolescents, paired with a lack of universally effective treatments, constitutes a significant public health concern. The goals of this project are to identify gut-brain signaling pathways that underlie anxiety and depression symptoms in adolescents, examine how they are impacted by environmental risk factors for psychopathology (adversity), and when in development they are most impacted. The long-term goal is to translate the research findings into novel microbiome-targeted therapeutics.